Nitric oxide as a novel regulator of alternative splicing

PROJECT SUMMARY/ABSTRACT
Protein post-translational modification (PTM) and alternative splicing enable the limited genome of a
cell to dynamically respond to environmental changes by diversifying its protein repertoire. Previous studies
have revealed that environmental cues impact alternative splicing through numerous PTMs of RNA-binding
proteins associated with the spliceosome. S-nitrosylation, the reversible covalent PTM of a protein cysteine
residue by the gaseous signaling molecule nitric oxide (NO) to form an S-nitrosothiol (SNO)-modified protein,
has been shown to alter protein function to play profound roles on cellular physiology, including the regulation
of gene expression. Specifically, S-nitrosylation is known to directly regulate key transcription factors as well
as to modify enzymes that alter the epigenome. Intriguingly, RNA-binding proteins of the heterogenous
nuclear ribonucleoprotein (hnRNP) family, including the polypyrimidine tract-binding protein (PTB), are
common in proteomic identifications of SNO-modified proteins under multiple conditions and in many cell
types. Because PTB is a master regulator of alternative splicing, we are exploring the central hypothesis that
NO enables a cell to dynamically regulate RNA splicing through SNO modification of PTB.
Our laboratory recently mapped S-nitrosylation to a single cysteine residue in PTB. Dramatic
alternations in gene expression when cells are exposed to NO are absent when this cysteine is mutated, strongly
supporting a role for SNO in regulating the activity of PTB with transcriptome-wide implications. This
proposal will interrogate these findings through three independent aims: Aim 1 will develop a bioinformatic
pipeline based on RNA sequencing analyses to identify specific alternative transcripts regulated by SNO-PTB,
including those that may have an outsized effect on global gene expression; Aim 2 will elucidate how SNO
affects PTB conformation and its association with protein and RNA components of the spliceosome, offering a
molecular mechanism for the influence of NO on alternative splicing; and Aim 3 entails the use of a conditional
knock-in mutant mouse in which PTB cannot undergo the SNO modification, allowing determination of the
physiological role of SNO-PTB by observing the consequences of dysregulated NO signaling.
This project will advance our understanding of the role of NO signaling as a crucial mechanism of the
cellular response to environmental cues through SNO-modification of a central regulator of alternative
splicing, PTB. Heretofore, global effects of NO on cellular function have been attributed to widespread
modification of proteins. The role of NO in regulating alternative splicing is previously unappreciated, and
provides new perspectives on dynamic regulation of cellular function in health and disease. This study will
thus define the role of NO in alternative splicing for the first time, potentially opening new areas of research.

Public health relevance
PROJECT NARRATIVE The gaseous signaling molecule nitric oxide is known to have important roles in regulating gene expression through numerous transcriptional pathways, enabling a cell to adapt to its environment by dynamically regulating the set of genes it transcribes. We have recently determined that nitric oxide, through covalent S- nitrosylation of cysteine residues in target proteins, also regulates alternative splicing of mRNAs, a crucial mechanism by which cells expand the protein-coding capacity of the genome. The goal of this project is to understand the effect of nitric oxide in regulation of alternative splicing through S-nitrosylation of a key RNA- binding regulatory protein, defining a novel fundamental role by which NO exerts global effects on gene expression profiles in health and disease.